Translational Science BioCore Shared Resource

PROJECT SUMMARY / ABSTRACT
The mission of the Translational Science Biocore (TSB) is to facilitate basic and translational cancer research
by providing UWCCC members with a comprehensive array of services that enable cellular and molecular
characterization of human derived biospecimens. Aim 1 is to collect and distribute human derived
biospecimens. TSB operates with Institutional Review Board (IRB) approval to prospectively collect, store, and
distribute a wide variety of human tissues and body fluids from patients being treated within our hospitals and
clinics. Standard Operating Procedures have been established to ensure the collected biospecimens meet
specified quality parameters. TSB is authorized by the IRB to serve as an ‘honest broker’ and provide
investigators with needed clinical and demographic annotations that are coded in a manner that protects
patient confidentiality. TSB also provides biospecimen collection, processing, and storage services to UWCCC
members who direct project specific, IRB-approved protocols. Aim 2 is to construct and distribute disease
specific tissue microarrays (TMAs). TSB pathologists review archival tissue blocks to identify specimens well
suited for inclusion in each disease specific TMA, which is then constructed by TSB staff. Each TMA is fully
annotated with relevant clinical data and is distributed to UWCCC members following appropriate institutional
review. Aim 3 is to provide molecular pathology and imaging expertise and infrastructure. TSB pathologists and
expert staff consult with UWCCC members to guide development, conduct, and interpretation of studies that
utilize human derived biospecimens and also provide broad expertise and services in a variety of molecular
pathology applications, including morphometric analysis of stained tissue sections, quantitative analyses of
specific molecular phenotypes, laser capture microdissection, in situ hybridization, and immunohistochemistry.
TSB houses the state-of-the-art instrumentation required for each of these services; e.g., Vectra and Nuance
multispectral imaging platforms and Aperio digital pathology whole slide scanner. TSB also provides an
assortment of basic histopathology support services on human derived biospecimens. Finally, TSB provides a
cell line authentication service to assist UWCCC members in meeting NIH requirements for scientific rigor and
reproducibility. Impact on UWCCC: TSB has achieved many noteworthy milestones during the current CCSG
funding cycle. During this period, we have increased the volumes of biospecimens collected and distributed,
the numbers of protocols and trials supported, and the number of UWCCC members served. We continuously
evaluate the needs of the UWCCC research community and strive to address all identified needs in a timely
manner. We have enhanced our existing services and have added new services to enable our members to
perform innovative research that advances the UWCCC mission.